URSODEOXYCHOLIC ACID THERAPY IN CHRONIC CHILDHOOD CHOLESTASIS

To investigate the ability of Ursodeoxycholic Acid (UDCA) to reduce prurititis, hyperbilirubinemia, and hypercholesterolemia, possibly decrease ongoing liver damage and improve quantitative tests of hepatic function in patients with long-standing cholestasis.